Finessing the details: subclasses of LGN neurons and the richness of spatial transcriptomics

PROJECT SUMMARY / ABSTRACT
Evidence is slowly building for a more nuanced and complex architecture within human and macaque
lateral geniculate nucleus (LGN) than the classic view of three cell classes separated into six laminae.
Exhaustive investigations in primate retina have revealed a highly diverse set of retinal ganglion cell (RGC)
types that project to the LGN; while the majority of projections by ﬁber count are from the primary classes
of RGCs (midget and parasol) that target the magno- (M) and parvocellular (P) layers in LGN, many of the
classes with sparser ﬁber count (bistratiﬁed, thorny, sparse, monostratiﬁed, etc.) project to the koniocellular
(K) layers, or have undescribed targets in the LGN.
Recent single cell RNA sequencing (scRNA-seq) results on neuronal nuclei microdissected from diﬀer-
ent layers of LGN suggest a broader diversity than currently understood by classical anatomical and funct-
ional results, with eight cell types identiﬁed in macaque: four GABAergic cells (presumably interneurons),
M, P, and two kinds of K cells. Our analysis of data from the literature, presented here, suggests that
additional sub-classes can be identiﬁed. But the spatial distribution of those cell types, speciﬁcally the
multiple GABAergic and K classes, and the novel sub-classes we have found, is as-yet unknown.
We will ﬁll that gap by applying the recently available tools of spatial transcriptomics to analyze the
layout of geneticaly-deﬁned cell classes across the LGN, creating data sets from human autopsy tissue.
These data will be generated in collaboration with the UCLA Technology Center for Genomics and Bioin-
formatics on their NanoString CosMx SMI instrument. Human tissue will be obtained in collaboration with
the MGH Pathology Department through an unrelated program that requires rapid autopsy following death.
These data will allow us to test hypotheses about the spatial distribution of the factors that determine
the cellular subtypes above, such the NOTCH developmental pathway, NDUF, COX, and ATP metabolic
pathways, STX1A signaling pathway, and others. We will test whether diﬀerent LGN laminae within the M,
P, and K pathways are genetically diﬀerentiated, along with variation along eccentricity through anterior
vs posterior sections, or along projection columns.
The results from this initial project will be used as preliminary data in support of obtaining funding for
a larger, more extensive study that will look for variation within and across individuals, asking questions
about cell type distribution across the visual ﬁeld, within and across laminae, then between sexes, through
age, and ﬁnally about changes due to retinal or other blinding diseases.

Public health relevance
PROJECT NARRATIVE Having a map of the locations of diﬀerent cell types within the early stages of the visual system is critical to understanding how vision works, but we currently do not have that knowledge on a ﬁne enough scale. This research will help ﬁll that gap by using state-of-the-art techniques that allow measurements on each individual neuron in slides that will be sampled from human brains shortly after death.